The Development and Integration of Early Born SST-Expressing Interneurons in the Cortex

Project Summary
In this grant we propose three aims focused on exploring the following: (Aim 1) Determine the
efferent target selectivity of granular and infragranular SST cINs and determine the developmental
strategy by which this is achieved. (Aim 2) Explore the developmental molecular and cellular
basis by which SST cIN diversity is generated. (Aim 3) Identify and validate the SST prototypes
during late embryonic and early developmental periods that give rise to the nine SST cIN cell
types that populate the mature cortex.
A chief goal of my laboratory is to determine cortical interneuron diversity contributes
selectively to cortical function and how perturbations in these programs result in brain disease.
This grant is an exemplar of the multidisciplinary approaches that has become our hallmark and
combines individuals with skills ranging from molecular biology, transcriptomic analysis, genetics
and physiology. By combining these with the Fishell laboratory's expertise in development,
genetics and circuit formation, we will explore in this proposal how developmental programs in
SST cINs shape them selective synaptic connectivity.
Together, this grant represents a broad scale effort to both develop and test the
proposition that cortical circuits are much more precisely crafted such that the bewildering
diversity we have discovered in excitatory and inhibitory neurons reflects a level of circuit
organization that we are only beginning to understand. From our preliminary data it is evident
that canonical cortical circuits are much more precise and specific to particular subtypes. By
defining their relationships, as well as the molecular mechanisms that dictate their synaptic
specificity, this work will greatly increase both our understanding of cINs, as well as the
microcircuits they contribute to. This in turn will greatly extend our understanding of how
discrete cIN and pyramidal neurons interact in the obligate lock and key mechanisms that allow
their assembly.

Public health relevance
Project Narrative At present there exists a disconnect between the emerging diversity in interneuron cell types and its functional impact on cortical circuit organization. In the present grant we aim to demonstrate that there exists a presently unbeknownst selectivity of SST cINs for pyramidal and interneuron populations, such that cortical circuits are comprised of lock and key connections between specific subtypes. My proposal by coupling our expertise in studying the development of cortical interneurons, transcriptomics and both anatomical and optogenetic circuit cracking, promises to bridge this gap.